Development and evaluation of neuroimaging biomarkers of structural and functional network degeneration in Alzheimer’s disease

PROJECT SUMMARY
The Amyloid-Tau-Neurodegeneration (A/T/N) biomarker framework for Alzheimer’s disease (AD) indicates binary
(presence/absence) designations for each type of pathology. However, the anatomical information provided by
imaging modalities, particularly in assessment of neurodegeneration “N”, is not currently incorporated into this
framework. Further, preliminary data strongly suggests a dissociation between structural and functional brain
alterations in AD, a phenomenon likely reflective of underlying pathophysiology and not yet explored in the
literature. There is a clear opportunity for extending the ATN biomarker framework by incorporation of spatially-
defined neuroimaging biomarkers. A robust, validated approach for neuroimaging biomarker development uses
meta-analysis to define a node-and-edge model followed by validation in primary resting-state fMRI data. This
was recently successfully applied to multiple sclerosis, with upcoming clinical trials planned. The current proposal
utilizes a similar approach, with three aims: 1) to develop a meta-analytic node-and-edge model of structural
changes in AD; 2) to develop a meta-analytic node-and-edge model of functional changes in AD; 3) to determine
the ability of the models developed in Aims 1&2 to detect clinical (healthy à mild cognitive impairment àAD)
and pathological (healthy à A+ à A+T+ à A+T+N+) progression of AD. Aim 3 will utilize primary resting-state
fMRI data from the Alzheimer’s Disease Neuroimaging Initiative. Directly, completion of the proposed aims will
provide characterization of the dissociation of structural and functional changes in AD (Aims 1&2) and a spatially-
based functional connectivity imaging biomarker for disease progression along the AD continuum (Aim 3).
Longitudinally, knowledge gained from the proposed project will advance the understanding of AD
pathophysiology, allowing for development of targeted therapeutics, and ultimately decreasing morbidity and
mortality from neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Biomarkers play an expanding role in Alzheimer’s disease (AD) research; the amyloid, tau, neurodegeneration (A/T/N) framework describes AD biomarkers by providing a binary (positive/negative) classification scheme for each category. However, this framework ignores the anatomical distribution of pathology, which may provide vital information on AD pathogenesis, symptomology, and treatment response. Here, we propose the development of a spatially-based neuroimaging biomarker for AD, which will directly aid in monitoring disease progression and has great potential to accelerate discovery of therapeutics targeted to underlying neuropathology.